A Machine Learning Algorithm to Assess Functional "Brain Age" from an In-Home EEG Sleepband

1 PROJECT SUMMARY
2 Humans are living longer, resulting in our bodies outliving our brains. Although behavioral changes and better
3 management of health conditions can help reverse or slow down premature decline in brain function, pre-
4 symptomatic adults are not identified early enough when these changes would make the most significant positive
5 impact. Effective intervention requires early detection before irreversible brain damage occurs, but there is a lack
6 of objective, scalable tools to assess brain function in pre-symptomatic adults.
7
8 Brain Age (BA) is a biomarker that can be used for early detection of deterioration in brain function. BA reflects
9 an individual’s age-adjusted structural and/or functional brain characteristics and has been shown to detect
10 cognitive impairment. While effective, the cost and inconvenience of current assessment methods (e.g., MRI,
11 polysomnography) prevent widespread usage of BA as a biomarker. Therefore, there is a clear unmet need for
12 a new method for assessing BA.
13
14 NeuroGeneces’ BA machine learning (ML) model, using at-home sleep data, will provide an objective and
15 interpretable measure of age-adjusted brain function. In this Phase I STTR project, NeuroGeneces will expand
16 the dataset of sleep recordings by conducting a Human Subject Study and validate the feasibility of a ML model
17 that accurately predicts biological BA in cognitively healthy adults using an at-home sleep EEG headband.

Public health relevance
PROJECT NARRATIVE Cognitive decline is a primary health concern of adults over 45 years old. Although Brain Age (BA) has been proven to be a biomarker for early detection of deterioration in brain function, current approaches for BA assessment are ineffective, expensive, or inappropriate for large-scale screening. NeuroGeneces’ machine learning BA model for BA assessment, fed by a low-cost, home-based EEG sleep headband, could provide an early, objective assessment of brain function.